Tracking and Evaluation Core

The Tracking and Evaluation (TE) Core of the West Virginia Clinical and Translational Science Institute
(WVCTSI) uses collaborative capacity building evaluation and accountability frameworks to assist all cores in
their evaluation and data-based decision-making processes, empowering core personnel to recognize and
address challenges to productivity and desired outcomes. No evaluation entity with the infrastructure and
resources to accomplish programmatic evaluation at this scale existed here prior to WVCTSI funding. During
Years 1-10, TE Core established robust systems and processes to provide leadership and personnel with
objective performance data to assess progress toward Aim achievement. In this second renewal application, TE
proposes innovative new initiatives to enhance the WVCTSI’s capacity to evaluate its progress, maximizing
accountability and programmatic improvement. These efforts will be accomplished through the following specific
aims: 1) Leverage creative existing platforms to further increase capacity among WVCTSI personnel outside of
TE Core to rapidly translate evaluation findings to practice through innovative evaluation data science resources
and regular evaluation data use training workshops; 2) Drive quality improvements in WVCTSI services and
support through investigator-centric programmatic evaluation that enables clinical/translational (C/T) investigator
productivity; and 3) Develop and a disseminate portable toolkit of programmatic evaluation models that drive
continuous quality improvement and demonstrate statewide impact on rural health and healthcare. For aim 1,
TE Core will increase the capacity of WVCTSI personnel to rapidly translate evaluation findings to practice by
identifying recurring evaluation data needs and developing user-friendly web-based data science resources that
provide data visualizations in near real-time and also providing regular training in utilization of these resources
and data-based evaluative thinking. For aim 2, TE Core will develop a central database logging every instance
of service delivery to investigators and associating that data with all other investigator data points. Analyses of
these data will guide qualitative work with investigators to identify and remove barriers to their productivity
through improved services and service delivery by all cores. For aim 3, TE Core will develop and package for
portability two evaluation data models that focus on a) PBRN connectivity and impact on rural health and
healthcare, and b) hub-and-spoke knowledge transmission to support rural health care providers and positively
impact their patients. Three key innovations involve: a) sophisticated data science tools and evaluation capacity
building to rapidly translate evaluation findings to practice, b) driving quality improvement through investigator-
centric programmatic evaluation, and c) disseminating a portable toolkit for programmatic evaluation in rural
health and healthcare settings. Integrating these key innovations into the programmatic evaluation developed
during the current WVCTSI funding cycle will allow rapid transformation of WVCTSI toward sustainability and
accomplishment of the overall programmatic goals of this application.